A Wearable Sensor Platform for Remote Monitoring of Motor Impairment in Huntingtons Disease and Prodromal Huntingtons Disease

ABSTRACT
The principal means of measuring motor impairment in Huntington disease (HD) is the Unified Huntington’s
Disease Rating Scale total motor score (UHDRS-TMS). Although valuable, the scale is subjective and
categorical, and requires significant training to administer correctly. To address some of the challenges and
shortcomings associated with UHDRS-TMS, we have developed a wearable sensor, called HDWear, for
continuous monitoring of chorea and physical activity in individuals with HD. As a part of this development, we
have enrolled 41 participants (21 with clinically diagnosed HD, 8 classified as prodromal HD, and 12 controls
age-matched to HD participants) at the University of Rochester Medical Center who agreed to periodic
monitoring over 12 months using HDWear. This study represents one of the longest monitoring of individuals
with HD and prodromal HD using wearable sensors ever conducted and validated the utility of HDWear for
monitoring physical activity and chorea in HD patients. In this study, HD participants exhibited no significant
change in UHDRS-TMS, while there was a significant decrease in physical activity level from baseline to 12-
month. However, physical activity level in prodromal HD participants did not change over the 12-month
monitoring period, highlighting the need to develop more sensitive metrics to capture progression of motor
impairment in these individuals during early onset of the disease. This is especially important since most
therapeutics under development are targeting prodromal and early-stages of HD to slow down the progression
of the disease. In this regard, our preliminary results, as well as other recent published papers, suggest that
speech and cognitive function changes, along with motor assessment, can lead to better characterization of the
onset of symptoms in prodromal HD.
In this Direct Phase II SBIR, we propose to build upon HDWear by developing a comprehensive remote
monitoring solution for individuals with HD and prodromal HD called HDWear+. In addition to a wearable sensor,
HDWear+ includes digital speech and cognitive assessments and enables the collection of patient-reported
outcomes (PROs) related to quality of life and functional ability, as well as a medication diary. We will use
HDWear+ to monitor and follow a large cohort of HD and prodromal HD (including 25 HD, 25 prodromal HD and
25 controls) for 12 months. We will evaluate the sensitivity of HDWear+ for monitoring changes in motor, speech,
and cognitive function in individuals with prodromal HD and HD. Moreover, we will develop a machine learning-
based model for automatic assessment of dysarthria in HD. In accordance with regulatory processes for the
adoption of novel technologies, we will conduct interviews with participants at baseline, 6, and 12 months using
the Technology Acceptance Model (TAM) to examine perception of benefit, technology acceptance,
technological anxiety, trust, facilitating conditions, perceived risk, and attitude of use from the point of view of
patients. We will also use Usability Metric for User Experience to measure the usability of HDWear+.

Public health relevance
NARRATIVE BioSensics has developed a wearable sensor, called HDWear, for continuous monitoring of chorea and physical activity in individuals with Huntington’s Disease (HD) and used HDWear to monitor 41 participants for 1 year. In this study, we will build upon HDWear by developing a comprehensive digital health technology for HD and prodromal HD called HDWear+ that includes a) wearable-based monitoring of chorea and activity, b) digital speech and cognitive assessments, and c) collection of patient-reported outcomes. We will use HDWear+ to monitor HD, prodromal HD, and controls participants for 12 months to evaluate the sensitivity of HDWear+ for monitoring changes in motor, speech, and cognitive function in individuals with HD and prodromal HD.